PheBC: bias correction methods for EHR derived phenotype

PROJECT SUMMARY
Phenotyping
drug
observational
to
records
advanced
required
refers to the process of identifying specific phenotypic patient statuses, such as disease status,
exposure, and treatment response. I is one of the most critical data extraction tasks in real-world
studies based on patient data. Traditionally, phenotyping has heavily relied on expert consensus
create phenotype definitions for individual diseases. However, with the widespread usage of electronic health
(EHRs) in clinical research and the development of artificial intelligence (AI) technologies, more
phenotyping efforts have been devoted to automated feature extraction, reducing the manual effort
to create precise phenotypes.
t
There
on
phenotyping
for
phenotyping
Our
phenotype
Specifically,
adding
We
research
are significant challenges in acquiring and reusing existing phenotyping information and algorithms based
electronic health records (EHRs) in a computable manner. Furthermore, in our current project, the
information extraction system and ias correction tool were originally designed as stand-alone tools
research purposes, we propose to develop a set of open services that f acilitate the sharing and reuse of
information extraction tools and bias correction tools in research communities.

overarching goa of t his Administrative Supplement is to disseminate machine-readable and computable
definitions and algorithms to reduce duplication of effort and improve reproducibility in clinical studies.
the two specific aims are: (1) Enhance the reusability of phenotyping information extraction tools by
APIs and services. (2) Engage research communities to promote the adoption of bias correction tools.
plan to refactor our software architecture and user interfaces to enhance the adoption of our tools among
communities.
b
l

Public health relevance
Narrative Our goal for this Administrative Supplement is to disseminate machine-readable and computable phenotype definitions and algorithms to improve reproducibility in clinical studies. Our specific aims are to enhance the reusability of phenotype extraction tools and promote the adoption of bias correction tools. We will refactor our software architecture and user interfaces to achieve these aims.